Administrative Core

The Center for Cell Signaling Research is committed to the career development of its investigators and to building unique
research infrastructure and capabilities at UNE to enhance the University research enterprise. Central to these goals is an
effective Administrative Core. The Administrative Core executes the mentorship and career development plans of its
Project Leaders (Research Project Leaders and Pilot Project Leaders), sets benchmarks for success, monitors research
progress, assesses the performance of the research core, and manages Center finances. The Core will be led by the
Program Director, in close collaboration and with the guidance of the Advisory Committee, which includes 2 institutional
leaders and 3 external scientific leaders in the field. The Advisory Committee provides general programmatic advice to
the Program Director and timely feedback to the Research Project Leaders. The Advisory Committee also evaluates and
recommends pilot project proposals and replacement Research Project Leaders for COBRE funding, ensures continued
institutional support for the program and facilitates the removal of any institutional barriers that might impede the
Center’s success. The Administrative Core will promote collaboration and Research Core synergies by coordinating its
efforts with the UNE Phase 3 COBRE for pain research and other regional COBREs. The Administrative Core will carry
out its functions by: 1) Coordinating and executing the mentorship plan for Research Project and Pilot Project Leaders. A
mentorship team, with the assistance of a highly engaged Advisory Committee, ensures that Center investigators receive
the necessary scientific and career development advice for attaining independent investigator status. Clear milestones are
defined and progress is evaluated; 2) Administering a pilot project grant program. Annual solicitations for pilot project
proposals will be made, and projects will be reviewed by an ad hoc committee that includes senior investigators and
Research Project Leaders. The Advisory Committee will perform a final review and provide the Program Director with
funding recommendations. Pilot project grant recipients will receive mentorship similar to Research Project Leaders, and
will undergo an annual research performance review; 3) Leading recruitment efforts for new tenure-track faculty. Tenure-
track faculty will be recruited with research programs that align with the Center’s focus; 4) Overseeing the fiscal
management and evaluation of the Center to ensure that the center is on track to meeting its overall goals. The
Administrative Core will conduct annual evaluations of the research core and Project Leaders. Action plans in response to
these evaluations will be implemented to ensure that investigators remain on track for manuscript and grant submissions,
and that the research core remains responsive to user needs. Continued education of the Program Director, e.g., attendance
at national and regional IDeA symposia, will ensure the implementation of current COBRE best practices.